Resources to Advance Pediatrics and HIV Prevention Science (RAPPS): Preclinical Gap- Filling Services

The objective of the Resource to Advance Pediatrics and HIV Prevention Science contracts is to provide the extramural scientific community with research materials and preclinical product development support for candidate products that emerge from investigator-initiated research studies, or from collaborations with private sector or academic partners. These services may also be used to support product discovery and development leading to IND, Investigational Device Exemption (IDE), and/or New Drug Application (NDA) filings with the FDA. NIAID will primarily use these contracts to fill critical development and resource gaps more rapidly and efficiently and advance promising products into clinical testing. The focus of these contracts will be development of therapeutics and prevention products for HIV, including single or combination products with activity against associated co-infections or MPTs that incorporate contraceptives.

Public health relevance
The objective of the contract for Resource to Advance Pediatrics and HIV Prevention Science is to provide the extramural scientific community with research materials and preclinical product development support for candidate products that emerge. The focus of these contracts will be development of therapeutics and prevention products for HIV, including single or combination products with activity against associated co-infections or MPTs that incorporate contraceptives.